Fatty acids and their receptors-mediated tumor metastasis and progression

Overcoming metastasis and resistance to chemotherapy remains a major unmet need for colorectal cancer
(CRC), despite significant progress made in the molecular characterization and understanding of metastatic
CRC. RAS and BRAF mutations (occur in 50% and 10% of CRC patients, respectively) are known to have
worse overall prognosis and/or clinical outcome. However, no inhibitors, including those against RAS pathway
and BRAF mutation, are able to overcome CRC progression. Increased adipocytes and lipids associated with
obesity/diet that accumulate at tumor sites as in CRC are recognized as critical for cancer metastasis and
resistance to therapy. Although CD36 is well-documented as a lipid transporter that plays an important role in
initiating metastasis and therapy resistance, our preliminary studies indicate that CD36 is only partially
responsible for lipid uptake in CRC tumor cells. Moreover, MDR1, known for its function in pumping out drugs,
co-expresses with CD36 and plays a role in lipid uptake into metastatic initiating/chemo-resistant CRC cells.
The nature of lipid species transported by CD36 and MDR1 critical for initiating metastasis and resistance to
apoptosis is unknown. We therefore propose to (1) determine the specific roles of MDR1 and CD36 as fatty
acid receptors and elucidate the oncogenic lipids they transport in mediating tumor metastasis in CRC; (2)
investigate how excess lipids fail to cause lipotoxicity while promoting metastasis and resistance to apoptosis
of CRC cells with RAS and BRAF mutations. Our published data demonstrate that STAT3 upregulates fatty
acid oxidation (FAO), leading to increased cancer cell stemness, which is important for metastasis and drug
resistance. We further demonstrated in preliminary data that extra acetyl-CoAs, generated by increased FAO,
activate STAT3 by acetylation, which in turn upregulates Acyl-CoA synthetases (ACSL), supporting lipid
catabolism and phospholipid biogenesis. We will test the hypothesis that the fatty acid receptors, CD36 and
MDR1, mitigate lipotoxicity and resist apoptosis through enhanced phospholipid biosynthesis and heightened
mitochondrial integrity. Our preliminary data are indicative that acetylated STAT3 is critical for metabolizing
excess lipids and for fatty acids-mediated resistance of CD36+MDR1+ CRC cells to apoptosis by increasing
mitochondrial membrane potential, which will be further validated in Aim 2. We therefore propose to (3)
validate acetylated-STAT3 as a target for controlling CRC metastasis and chemo-resistance in highly
metastatic CRC xenografts and in metastatic patient-derived xenografts (contain either RAS or BRAF
mutations). To this effect we will utilize our newly developed cell-penetrating acetylated-STAT3 decoy peptide
that effectively and specifically targets activated (acetylated) STAT3. Our proposed studies will provide
mechanistic insights into tumor progression mediated by increased lipids in the tumor microenvironment. They
may also lead to more effective therapeutic interventions for CRC with various genetic mutations.

Public health relevance
Overcoming metastasis and resistance to chemotherapies remains a major unmet need for colorectal cancer (CRC). We propose to gain a precise understanding of the molecular mechanisms by which lipids promote CRC metastasis and resistance to current therapies, followed by developing novel and effective approaches to control chemo-resistance and tumor progression.